Core A - Administrative Core

The Administrative Core (Core A) of the Antiviral Countermeasures Development Center (AC/DC) will provide
effective leadership, oversight, coordination, administration, and evaluation of all Center activities across the 12
participating sites. The primary goal of Core A is to ensure the seamless operation of all components of the
AC/DC such that the Research Projects and Scientific Cores remain focused on the overall mission: To develop
orally available direct-acting clinical candidates against existing and emerging pandemic viral threats. Core A
will facilitate collaboration and communication among Center investigators and be responsible for the overall
scientific direction of the Center. This includes monitoring and evaluating progress of the Research Projects,
promoting new research ideas through administration of Developmental Research Projects (DRP), and
mentoring new investigators in the field of antiviral research through Mentored Projects (MP). The Core will be
responsible for maintaining fiscal oversight of all Center components including Research Projects and Scientific
Cores and managing all subcontracts. Core A will ensure compliance with all local and federal regulations. The
Core will coordinate Steering Committee (SC) and Scientific Advisory Board (SAB) meetings, prepare annual
progress reports, and interact with other NIAID AViDD centers nationally and with NIAID program officials. The
overall goals of the Administrative Core are: (1) Provide effective scientific and operational management of the
AC/DC; (2) Coordinate the evaluation and oversight of the AC/DC; (3) Administer the Developmental Research
Projects and Mentored Projects to promote new ideas and new investigators and to enhance diversity in the field
of antiviral research.